California Center for Population Research (CCPR) at UCLA

Overall – Project Summary This application requests P2C infrastructure support for the California Center for Population Research (CCPR) at UCLA. With 70 faculty fellows from across the university and 12,620 sq. ft. of research space, CCPR's central goal is to stimulate and support innovative and ambitious interdisciplinary research on the most important issues in population science. To accomplish this goal, CCPR: (1) mentors and supports early stage investigators in population research; (2) creates a supportive and intellectually stimulating environment for interdisciplinary interaction and collaborative research; (3) provides high quality services that increase the pace, efficiency, and impact of research; (4) encourages the development and use of novel research methods and approaches; (5) provides access to population data and supports new data collection; (6) assists affiliates in disseminating their research and data to a variety of audiences; (7) regularly and systematically evaluates Center services to improve efficiency and cost-effectiveness. CCPR's Primary Research Areas address fundamental questions about population dynamics. Affiliates' research now and over the next year will examine: Family demography, household dynamics, and individual well-being; Migration and immigration; Health disparities; and Reproductive health. We request supplemental funding for the Administrative Core. The Administrative Core prioritizes and coordinates all CCPR activities, creates and maintains the environment needed for interdisciplinary research, and provides efficient, cost-effective financial and administrative services. The Administrative Core provides support for proposal submission and grant managements. It also provides the administrative services needed to support our weekly seminar series, developmental workshops, conferences, and public lectures.

Public health relevance
Overall – Project Narrative PUBLIC HEALTH RELEVANCE: CCPR research increases scientific knowledge of population dynamics and their effects on reproductive and population health. Future improvements in public health require deeper understanding of the demographic and social determinants of health and, conversely, the effects of health on population dynamics and socioeconomic status. An administrative supplement will enable CCPR to continue to support research that seeks to understand these processes to improve public health.